Graduate Training in Occupational Health Psychology and Total Worker Health

Program Director: Liu-Qin Yang, Ph.D.
Project Summary/Abstract
We are currently seeking a 5 year renewal for our Training Program Grant in Occupational
Health Psychology (OHP) which has now been expanded to OHP-Total Worker Health. We are
requesting support for a total of 4 full time doctoral students per year. Funded as the first OHP
training program grant (TPG) in June of 2002, our program has served as a model for the
development of other OHP programs. We received a 5-year renewal in June of 2005, another 5
year renewal in June 2010, and then another 5 year renewal in June 2015-June 2020. The
graduate training program at Portland State University (PSU) is designed to address a growing
discipline of Occupational Safety and Health (OSH), namely, Occupational Health Psychology
(OHP), and the newly emerging discipline of Total Worker Health® (TWH). Our trainig program
has been squarely focused on OHP for the past 17 years and is now being modified as part of
our renewal to include TWH. OHP-TWH is an interdisciplinary field that involves the application
of psychological principles for improving the quality of work-life and for promoting the safety,
health, and well-being of people at work. OHP-TWH researchers and practitioners draw from
the domains of public health, preventive medicine, nursing, industrial engineering, law,
epidemiology, and psychology to develop sound theory and practice for protecting and
promoting safety, health, and well-being in the workplace, such as through implementing
interventions to eliminate or control workplace hazards and encouraging workplace
enhancements to foster worker health and well-being.
To date we have graduated a total of 28 students, with 8 of those graduating in the past 4
years with the OHP minor. All are employed in related fields using their OHP knowledge and
skills. We currently have 16 students in the program. Our students have been placed in
nationally-recognized internship programs and upon graduating they have been placed in
academic, government, and industry jobs related to OHP and TWH. Over the years, our
program has filled a need for specialized training in OHP, as well as a need for TPGs in our
region. During this funding period we proactively sought ways to ensure that we have a strong
multidisciplinary focus in the program and have significantly increased our collaboration with
faculty at the Oregon Health and Sciences University (OHSU) through our participation in the
Oregon Healthy Workforce Center (OHWC) described in the proposal. We have been involved
in the development of the joint PSU-OHSU School of Public Health, and we have strengthened
our ties with the University of Washington-ERC and the School of Public Health at Oregon State
University. Through these interdisciplinary and inter-institutional connections, we have
significantly expanded our program's focus from OHP to OHP-TWH, through expanding our
required and elective OHP-TWH courses and research/internship/job opportunities for our
trainees, as well as disseminating evidence-based OHP-TWH solutions to the national and
international communities via both the biennial summer OHP-TWH institute and annual fall
symposium on OHP-TWH. Furthermore, we have a wealth of methodology courses (e.g., Multi-
Level Modeling, Structural Equation Modeling) for students. We have also joined the
Consortium for the Advancement Research Methods and Analysis (CARMA) including webinars
as an additional methodological resource for our students. The primary long term goals of our
program are to provide formal graduate training in OHP-TWH and to serve as a national model
for OHP-TWH training that successfully balances science and practice perspectives while
remaining multidisciplinary in nature, and to support a developing graduate certificate in TWH
that spans across Portland State Univeristy and Oregon Health and Science University.

Public health relevance
Project Narrative We are seeking renewal funding for our graduate training program at Portland State University (PSU) in an under-represented, but growing discipline of Occupational Safety and Health, namely, Occupational Health Psychology (OHP). OHP is an interdisciplinary field that involves the application of psychological principles for improving the quality of work-life and for promoting the safety, health, and well-being of people at work. OHP researchers and practitioners draw from the domains of public health, preventive medicine, nursing, industrial engineering, law, epidemiology, and psychology to develop sound theory and practice for protecting and promoting safety, health, and well-being in the workplace. We are seeking to innovate this training by expanding to include Total Worker Health®.